Investigating the PD-L1:NLRP3 signaling axis as a tumor intrinsic mechanism of adaptive resistance to anti-PD-1 antibody immunotherapy

Despite the positive impact that checkpoint inhibitor immunotherapy has had on the field of
oncology, the majority of our cancer patients do not respond to this treatment strategy. It is clear
that a more complete understanding of these mechanisms driving resistance to checkpoint inhibitor
immunotherapy will lead to the development of more effective immunotherapy regimens and to
improved patient selection for specific therapies. However, our understanding of active tumor-
mediated resistance mechanisms that are more responsive to pharmacologic targeting remains
poor. Myeloid-derived suppressor cells (MDSCs) are an immunosuppressive cell population that
have been correlated with inferior responses to checkpoint inhibitor therapy. Using pre-clinical
models of different tumor types as well as clinical specimens harvested from melanoma patients,
we have found that resistance to anti-PD-1 antibody (ab) immunotherapy is associated with the
recruitment of granulocytic MDSCs (PMN-MDSCs) into the tumor bed. Subsequent mechanistic
studies were conducted to understand the molecular underpinnings for this accumulation of PMN-
MDSCs in tumors undergoing checkpoint inhibitor immunotherapy which noted that CXCR2-
dependent chemokines are upregulated in response to a Wnt5a-YAP1 signaling axis and that this
pathway is triggered by the release of heat shock protein-70 (HSP70) by tumors in response to
CD8+ T cell activation. Using a genome-wide CRISPR screen, we have determined that the tumor
NLRP3 inflammasome is essential for the induction of this signaling cascade and the ultimate
recruitment of PMN-MDSCs to the tumor bed. Based on this cumulative data, we hypothesize
that the adaptive recruitment of PMN-MDSCs and its subsequent suppression of effector T cell
activity in response to anti-PD-1 ab immunotherapy is mediated by activation of the tumor NLRP3
inflammasome via tumor intrinsic PD-L1 signaling. We further propose that the pharmacologic
inhibition of the NLRP3 inflammasome will enhance the efficacy of anti-PD-1 ab immunotherapy
in an autochthonous model of BRAFV600E melanoma and that genetic mutations impacting this
pathway can lead to differential responses to checkpoint inhibitor immunotherapy. In addition to
modeling specific gain-of-function NLRP3 mutations in pre-clinical melanoma models, we will
also leverage an ongoing clinical protocol designed to harvest tissue specimens from melanoma
patients, enabling the association of NLRP3 genetic mutations and expression levels, PMN-MDSC
tumor infiltration, and clinical response to checkpoint inhibitor immunotherapy. Overall, this
study promises to contribute significantly to our understanding of adaptive resistance to anti-PD-
1 ab immunotherapy in cancer.

Public health relevance
This work will provide critical scientific insight into a novel adaptive resistance mechanism to anti-PD-1 antibody immunotherapy in cancer. These proposed studies are designed to characterize the NLRP3 inflammasome as a therapeutic target and biomarker capable of enhancing the efficacy of anti-PD-1 antibody immunotherapy. Therefore, this approach promises to provide a previously unrecognized immunotherapeutic target that will expand the cancer patient population responding to checkpoint inhibitor immunotherapy as well as a biomarker allowing for improved patient selection and more optimal tailoring of immunotherapy regimens to specific cancer patients.